HDAC1 Regulation of Endothelial NO

PROJECT SUMMARY Excess sodium intake accounts for billions of healthcare dollars every year. In 2010, 1.65 million deaths from cardiovascular disease were attributed to a high salt diet. Furthermore, sodium intake directly correlates with kidney function and mortality. A high salt diet causes cardiovascular and renal damage by increasing oxidative stress and impairing endothelial nitric oxide (NO) signaling. The mechanisms by which a high salt diet leads to NOS3 uncoupling and increased NADPH oxidase 2 (Nox2) expression and activity remains elusive. NOS3 uncoupling is characterized by an increase in NOS-dependent reactive oxygen species (ROS) and a decrease in NOS-dependent NO. The central hypothesis to the proposed studies is that high salt increases endothelial HDAC1 which uncouples NOS3 via post-translational modification (deacetylation) and increases Nox2 expression and activity via a transcriptional mechanism. In order to study the role of HDAC1 in NOS3 uncoupling, intra-renal arteries and renal endothelial cells will be isolated from normal and high salt fed rats. HDAC1 activity as well as HDAC1 dependence of NOS3 uncoupling and NOS3 acetylation will be assessed. We will generate vascular endothelial HDAC1 knockout (VEHDAC1KO) mice to investigate the necessity of HDAC1 in high salt disrupted NO signaling. The juxtamedullary nephron preparation will be used to assess NO signalling in small intra-renal arteries. In order to identify which NOS3 lysines are susceptible to HDAC1 deacetylation, we will utilize NOS3 constructs containing specific lysine (K) to arginine (R) or glutamine (Q) mutations. Cdh5- CreERT2-Nox2KO mice will be used to assess the role of endothelial Nox2 in high salt disrupted NO signaling in small intra-renal arteries. We will use VEHDAC1KO mice to elucidate the role of HDAC1 in high salt increased Nox2 complex expression. ChIP-qPCR will be utilized to assess the effect of HDAC1 on histone modifications at the promoters of the genes of the Nox2 complex. The long-term goal of this project is to understand the role of HDAC1 in endothelial NO signaling in order to develop novel therapies for cardiovascular disease.

Public health relevance
PROJECT NARRATIVE High salt intake contributes a substantial burden to human health. High salt induced cardiovascular and renal damage is in part mediated by decreased bioavailability of endothelial nitric oxide and increases the risk of future cardiovascular complications. This project aims to elucidate new drug targets by investigating the in-depth mechanisms by which a high salt diet decreases endothelial nitric oxide bioavailability.